Maternal-Fetal Medicine Units (MFMU) Networks

The purpose of this proposal is to summarize the resources at Magee Womens Hospital
of the University of Pittsburgh Medical Center (UPMC) and to demonstrate how we will
continue to contribute meaningfully to the mission and objectives of the NICHD-sponsored
Maternal-Fetal Medicine Units Network. Our Unit has been an active participant in single- and
multi-center observational and interventional clinical studies for three decades, including
the NuMom2b network, and the Obstetric-Fetal Pharmacology Research network, and
the MFMU Network. Our track record establishes that we have demonstrated our willingness to
cooperate with other institutions and the NICHD in the development and implementation of
clinical research protocols. We have been active participants in every aspect of multicenter
networks. We have proposed protocols, have served on subcommittees of other protocols, have
served on administrative subcommittees, and have served as site visitors to evaluate other
centers. We have effectively recruited patients and have provided intellectual input in the
development of new projects as well as the implementation of protocols from our center and
from others. The obstetrical unit at the University of Pittsburgh is one of the largest private
academic obstetrical services in the United States with over 10,000 deliveries annually.
Approximately 40% of our patients are deemed to be high risk prior to labor. The
demography of our population, detailed in this application, and our high enrollment rates
help ensure that results of Network studies are widely applicable across a diverse
spectrum of subjects. In this proposal we will: (1) describe our experience, infrastructure,
and track record of participation in single-center and multicenter studies of adverse
pregnancy outcome; (2) demonstrate our ability to enroll and provide maternal and
newborn follow-up to subjects enrolled in MFMU trials; and (3) delineate our unique
suitability in terms of technical and multidisciplinary content expertise to address the
objectives of the MFMU Network. We are enthusiastic about continuing to contribute to the
success of the MFMU Network and its continued pre-eminence in clinical research.

Public health relevance
The purpose of this proposal is to summarize the resources at Magee-Womens Hospital and the University of Pittsburgh and to demonstrate how we will continue to contribute meaningfully to the mission and objectives of the NICHD-sponsored Maternal-Fetal Medicine Units Network. We are enthusiastic about contributing to the success of the MFMU Network and its continued pre- eminence in clinical research.